The Impact of Soluble ST2 on Lung Injury Onset and Resolution

Project Summary
Candidate: Jehan Alladina, MD is a physician-scientist at Massachusetts General Hospital (MGH) and
Harvard Medical School (HMS). Her post-doctoral research interrogated type 2 (T2) immune pathways in
allergic asthma. Building on that work, this proposal investigates the role of T2 immunity in acute respiratory
distress syndrome (ARDS). The short-term goals of this K08 award are to provide training in murine models of
acute lung injury (ALI), longitudinal statistical modeling of patient data, and translational research. Dr.
Alladina’s long-term goal is to lead an independent research program on the host immune response in ARDS.
Training Activities: Dr. Alladina will perform the work outlined in this proposal at MGH under the mentorship
of Dr. Benjamin Medoff, an experienced mentor and expert in lung immunology; Dr. Eric Schmidt, a leading
expert in animal models of ALI and sepsis; and Dr Steven Skates, an accomplished biostatistician with
expertise in developing longitudinal algorithms to predict disease trajectory. Drs. David Christiani, Nuala
Meyer, and Anne Sperling will serve on Dr. Alladina’s advisory committee to provide further expertise in
longitudinal ARDS cohorts, molecular risk factors for ARDS, and mechanisms of lung inflammation and
resolution. Dr. Alladina will also complete didactic courses in immunology, biostatistics, and translational
research and will take advantage of the collaborative and rich intellectual environment at MGH and HMS.
Research: ARDS is the severe consequence of inflammatory lung injury and 40% of patients have progressive
disease characterized by persistent lung inflammation, fibrosis, and increased mortality. Identification of
immune regulatory pathways in ARDS, and how they change over the disease trajectory, could identify
biomarkers that predict outcomes and novel targets to prevent ARDS progression. Our preliminary animal and
human data demonstrate that T2 immunity is induced in ALI/ARDS and that IL-33, an upstream inducer of T2
inflammation, improves survival in a murine model of influenza-induced ALI. Moreover, soluble ST2 (sST2), an
endogenous inhibitor of IL-33, is associated with increased ARDS mortality and time on the ventilator. Thus, I
hypothesize that increased sST2 signaling blocks T2-mediated pro-resolution and repair pathways in ARDS,
leading to persistent pathological inflammation and fibrosis. To test this hypothesis, I will determine the causal
role of IL-33 and its endogenous inhibitor sST2 in ALI onset and resolution. I will leverage inducible transgenic
animals to manipulate IL-33 and sST2 expression early and late during ALI. I will also measure plasma and
airspace IL-33, sST2, and T2 cytokine levels in ARDS patients over time, and develop hierarchical longitudinal
models to differentiate as early as possible whether a patient will progress or recover. By leveraging murine
models and longitudinal human data, this proposal can establish both causality and relevance to human
disease. This K08 award would provide critical training for Dr. Alladina’s development as a successful
“bedside-to-bench” physician-scientist studying the immune mechanisms of ARDS progression and resolution.

Public health relevance
Project Narrative The acute respiratory distress syndrome (ARDS) is severe respiratory failure due to inflammatory lung injury, and immune regulatory pathways may dictate whether patients will develop progressive disease or recover. Our preliminary data in ARDS patients and using a mouse model of acute lung injury (ALI) revealed a role for one such pathway, IL-33-induction of type 2 immunity, in ALI recovery, with increased levels of an endogenous inhibitor (soluble ST2) of this pathway associated with worse ARDS clinical outcomes. The proposed work uses a mouse model of ALI and genetic tools to define the role of IL-33 signaling, and its regulation by soluble ST2, in lung injury and repair and leverages serial plasma and airway samples from ARDS patients to determine how markers of type 2 immunity predict disease trajectory and may reveal opportunities for early therapeutic intervention.